Learning Disabilities Translational Science Collective: Building on the Florida LDRC

The long-range objective of the Learning Disabilities Translational Science Collective is to build on successes
of the Florida Learning Disabilities Research Center to explicitly address the research to practice gap
associated with the identification and treatment of children with specific learning disabilities (SLD) in word
reading and reading comprehension. The Center is organized around the translational science continuum and
the concept of multi-disciplinary team science as a necessary approach to tackle complex public health
problems such as the study of SLD. To date, much of the research conducted in SLD classification and
treatment has not included samples that mirror the diversity of the country, raising questions of applicability of
existing research findings to diverse student populations. This Center has four research projects and three
cores (administrative, data management, and engagement) that work synergistically to address applied
research questions about SLD with diverse student samples. The research projects represent the translational
science continuum (T1-T4). Project 1 addresses identification, classification, and risk prediction of SLD. Project
2 (high risk) investigates the genetic and environmental influence on the responsiveness to intervention for
children who show early signs of reading risk. Project 3 (engagement) uses an implementation science
approach to better understand how to develop sustainable process for assessment systems in authentic school
settings. Project 4 will utilize population level screening data to better understand classification systems at
scale. Every project addresses the required theme of a substantial emphasis on diverse participants and has
embedded plans to engage early career researchers and community members to enhance the translation of
findings into practice.

Public health relevance
Project Narrative Successful uptake of research in authentic school and community settings requires the application of well- established, team-based, systematic approaches to translational science that combines research findings, stakeholder engagement, both quantitative and qualitative analyses, and iterative improvements. These approaches have great potential to close the research to practice gap by creating sustainable processes built for the contexts in which they will be used. With this LDRC, we expand upon previous successes to include studies beyond foundational science and with more diverse populations of students.